Elucidation of the Role of Setd8 and H4K20me1 in Erythropoiesis

Chromatin condensation is a key feature in the terminal maturation of many hematopoietic cell types, but
is particularly critical in erythroblasts, which undergo rapid nuclear and chromatin condensation in preparation
for enucleation. The average human must generate ~2.5 million red blood cells per second to maintain steady
state and avoid anemia. The process of generating an enucleate red blood cell from a committed erythroid
progenitor is extremely complex, and requires significant in gene expression during a time of rapid cell division
and chromatin condensation. Defects in chromatin condensation are particularly common in inherited anemias
and myelodysplastic syndromes, however the specific epigenetic mechanisms that regulate erythroid chromatin
condensation, and the relationship between chromatin condensation and gene expression are poorly
understood. The goal of this project is to delineate specific epigenetic mechanisms that regulate, and coordinate,
changes in gene expression and chromatin structure during terminal erythroid maturation. During the last funding
period, we demonstrated that maturing erythroid cells accumulate mono-methylation of histone H4, lysine 20
(H4K20me1). We further demonstrated Setd8, the sole enzyme capable of generating this mark, is essential for
erythropoiesis. Disruption of Setd8, and subsequent loss of H4K20me1, resulted in a profound defect in
transcriptional repression and defects in chromatin condensation, both globally and at specific loci. The overall
goal of this proposal is to delineate mechanisms by which Setd8 and H4K20me1 regulate erythropoiesis.
Mass spectrometry studies demonstrated that accumulation of H4K20me1 in maturing erythroblasts was
accompanied by loss of histone H4 K16Ac, which interferes with the association of neighboring nucleosomes
and promotes histone decompaction, as well as loss of histone H4 lysine 20 dimethylation (H4K20me2), which
decreases the ability of histone H4 lysine 20 to interact with epigenetic readers. We hypothesize that this
epigenetic transition is an important determinate of gene expression and higher order chromatin structure in
maturing erythroblasts. In specific Aim 1, we will determine the mechanisms that establish the H4 chromatin
landscape in maturing erythroblasts. H4K20me1 regulates chromatin structure and gene expression through
recruitment of epigenetic readers. The only H4K20me1 interacting protein expressed at significant levels in
erythroblasts is the Condensin II complex. We demonstrate that the Condensin II subunit NCAPH2 is essential
for erythropoiesis. Further, there is significant overlap in the transcriptomes of NCAPH2 / and SETD8 /
erythroblasts, supporting a model where Condensin II interacts with H4K20me1 to regulate gene expression
and chromatin structure during erythroid maturation. In specific aim 2, we will delineate the mechanisms by which
the Condensin II complex regulates terminal erythroid maturation. Together, these studies will provide novel
insights into the regulation of terminal erythroid maturation. As chromatin condensation is a common feature of
the terminal maturation of many cell types, these studies may have broad implications beyond erythropoiesis.

Public health relevance
Anemia, defined as an insufficient number of red blood cells, affects roughly one third of the world’s population and can be caused by a variety of factors that impair red blood cell production. The process by which functional red blood cells are produced from committed progenitor cells is incompletely understood. The studies outlined in this proposal will significantly enhance our understanding of how essential steps in red blood cell production are coordinated, providing much needed insights into a process fundamental to human health and disease.